Deconstructing interactions between diet, microbiome, and immunity to gain mechanistic insight into health and disease

Project Summary/Abstract
Intestinal immune responses are linked to the trillions of microorganisms that colonize the gastrointestinal tract.
Thus, inter-individual variations in the gut microbiome could contribute to altered immune responses that impact
immune driven diseases such as autoimmunity. Activation of T helper 17 (Th17) cells by members of the gut
microbiota can contribute to autoimmunity. Further, evidence is emerging that the diet influences both the
immune system and the microbiome. While the pairwise interactions between dietary factors, the microbiota,
and immunity have been broadly characterized, the field is just beginning to investigate the mechanistic interplay
between diet, microbiome, and immunity and the downstream consequences on autoimmunity. The goals of this
work are to investigate microbial mechanisms of Th17 cell activation, their diet-responsiveness, and the
functional consequences of these interactions on autoimmune diseases such as inflammatory bowel disease
(IBD) and multiple sclerosis (MS). Our preliminary studies reveal mechanistic insights into specific diet-
dependent factors that counteract specific pro-inflammatory gut bacterial species. Two prevalent human gut
species associated with human autoimmune diseases, Eggerthella lenta and Bifidobacterium adolescentis,
induce Th17 cells in the intestine in a diet-dependent manner. Dietary arginine and ketogenic diets (KDs) prevent
Th17 induction by E. lenta and B. adolescentis respectively. Further, a specific bacterial gene in E. lenta, cgr2,
is sufficient to activate Th17 cells. We aim to determine diet-dependent mechanisms of Th17 activation by E.
lenta metabolites and functional consequences IBD and MS mouse models. By combining immunological and
microbiome techniques with metabolomics and translational research expertise of our collaborators we aim to
identify a small molecule metabolized by E. lenta responsible for Th17 activation and assess the disease
relevance of dietary modulation of this metabolism. Secondly, we aim to examine the mechanism and disease
relevance of ketone bodies for limiting gut bacterial Th17 induction. A KD-associated gut microbiota reduces
intestinal Th17 cells via selective inhibition of bifidobacterial growth by the ketone body β-hydroxybutyrate (βHB).
Therefore, we hypothesize that the ketone body βHB selectively inhibits B. adolescentis-mediated Th17 induction
resulting in functional consequences for MS disease models. To address this hypothesis and elucidate the
mechanism by which βHB impacts the Th17 induction capacity of B. adolescentis, we will use bacterial genetic
manipulation and disease models. The proposed aims will leverage the candidate’s expertise in immunology and
microbiome studies with new training in metabolomics, bacterial genetics, and translational research studies.
UCSF’s institutional focus on the microbiome, metabolomics, immunology and translational research and close
collaboration with experts in these areas will provide an ideal environment for the proposed scientific and
professional development leading to the creation of an independent research program.

Public health relevance
Project Narrative Identification of diet-dependent mechanisms of commensal bacterial immune modulation could provide insight into autoimmune diseases such as inflammatory bowel disease and multiple sclerosis. Our study aims to investigate diet-dependent microbial mechanisms of Th17 cell activation, their consequences on mouse models of inflammatory bowel disease and multiple sclerosis, and relevance to human autoimmunity. The successful completion of our studies will provide important insight into novel bacterial mechanisms of Th17 induction and will probe whether dietary manipulation of bacterial immune-modulation represents a potential intervention for autoimmune diseases.